Neurological Surgery and Neurology research training in interdisciplinary neuroscience

The University of Washington has a long and robust tradition of training residents in the neurosciences for
careers as physician-scientists in academic medicine. This renewal proposal will combine the efforts of the
Departments of Neurological Surgery and Neurology to provide longitudinal interdisciplinary neuroscience
instruction, mentorship and support for residents engaging in dedicated research. The ultimate goal of the
project is fourfold: 1) Provide longitudinal interdisciplinary instruction on neuroscience research; 2) supervise
and mentor residents during dedicated 6-12 month research increments (extendable to up to 18 months); 3)
Prepare neurosurgery and neurology residents for careers as academic faculty physician-scientists with
independent research funding; and 4) Endeavor to recruit and retain diverse faculty and residents. Candidates
will pursue research with experienced faculty mentors in one (or more) of three research cores: Acute Neural
Injury/Neuroengineering, Neuro-Oncology, and Neurogenetics/Neurodegenerative Disease. Residents will
receive sustained scientific mentorship, formal instruction and career guidance throughout residency, including
specific instruction on the responsible conduct of research, rigor, integrity and ethics. Participants will develop
their own research hypotheses and experimental design, engage in high-quality, collaborative research both
during and beyond their dedicated research increments, and prepare an application for a mentored K-award or
similar independent funding in preparation for the transition to junior investigator. The leadership, resources,
environment and residents from both departments, when combined with the broader university-wide research
infrastructure, ensures that participants will be well-prepared to become leaders in collaborative research as
the next generation of neurosurgery and neurology physician-scientists.

Public health relevance
The goal of this research training program is to train outstanding academic physician-scientists in Neurological Surgery and Neurology. The program combines longitudinal interdisciplinary neuroscience instruction with strong faculty mentorship throughout their residency, and a structured resident research experience. Participants will complete the program with the necessary skills and experience to design and perform high- quality collaborative neuroscience research, acquire independent funding, and attain academic faculty physician-scientists appointments.